HIV, Gut Mucosal Turnover and Inflammation, and the Risk of Colorectal Neoplasia

ABSTRACT Population-based and endoscopic studies have suggested that the incidence of colorectal cancer (CRC) and its precursor, adenomatous polyps, is elevated in HIV-infected individuals compared with the general population. However, a specific mechanism explaining this high risk of colonic neoplasm has not been established. Gut epithelial turnover and mucosal inflammation are prominent in non-human primate models of HIV infection and is an important determinant of progressive HIV disease. Mucosal turnover and inflammation are further associated with the presence and development of adenoma in studies of uninfected individuals. The broad goal of this proposal is to characterize mucosal turnover and inflammation during HIV infection and their contribution to the risk of colorectal neoplasia. To this end, this application proposes (1) to determine the impact of untreated and treated HIV infection on mucosal turnover and inflammation compared to uninfected individuals, (2) to determine whether mucosal turnover and inflammation are associated with the presence of neoplasia in both HIV+ and HIV- individuals, and (3) to determine whether mesalamine decreases gut epithelial turnover and mucosal inflammation among HIV+ individuals in the context of an ongoing placebo-controlled trial. A major strength of this proposal is our ability to leverage a clinically well-characterized NIH-sponsored HIV-infected cohort (SCOPE) of over 1,360 subjects where 186 subjects have already undergone sigmoidoscopy and biopsies. Mucosal turnover and inflammation will be examined using archived tissue from SCOPE subjects (HIV treated, untreated, elite controllers, and uninfected) (aim 1). Recruitment from SCOPE will form the basis of a prospective cohort study correlating mucosal turnover and inflammation to colorectal neoplasia (aim 2). Aim 3 will measure the impact of mesalamine on mucosal turnover and inflammation as a substudy of a parent trial to reduce systemic inflammation in HIV-infected individuals. The resources from the K-award will allow me to rigorously examine mucosal changes secondary to HIV, develop a large cohort, build a tissue repository, and rapidly examine new hypotheses as they emerge. Indeed, this award will enable me to acquire didactic training, receive long-term mentorship, and hands-on research experience to become proficient in (1) conducting longitudinal clinical research, (2) clinic-based translational methodologies, and (3) advanced statistical methods promoting my transition to an independent research career. RELEVANCE: The current proposal will help confirm the HIV-attributable risk of colon cancer while providing important insights into the mechanisms mediating this risk. Our hypothesis derived from nonhuman primate studies is that HIV accelerates colonic epithelial cell turnover, which may drive the development of adenomas and carcinomas, is a logical and testable hypothesis and may have profound implications for the management of HIV disease, for informing appropriate screening guidelines, and for identifying targets for interventions in this setting. Moreover, disruption of the epithelial barrier also has important implications to HIV-associated comorbidities (e.g. systemic inflammation, cognitive decline, atherosclerosis, and immune senescence) to the extent that persistent microbial translocation increases the risk of these conditions via inflammatory pathways.

Public health relevance
PROJECT NARRATIVE Emerging data from a number of large studies and clinical trials suggest that despite effective medical therapy, HIV-infected individuals are still at higher risk for non-AIDS-associated cancers - including colon cancer - than the general population; however, a specific mechanism explaining this high risk of colonic neoplasm has not been established. Gut epithelial turnover and mucosal inflammation are prominent in non-human primate models of HIV infection and is an important determinant of progressive HIV disease. The broad goal of this proposal is to characterize mucosal turnover and inflammation during HIV infection, their contribution to neoplasia risk, and to examine whether intervention with mesalamine can normalize these parameters. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Despite significant strides in life expectancy in the modern antiretroviral therapy (ART) era, HIV- infected individuals remain at higher risk for colorectal cancer (CRC) and other non-AIDS- associated malignancies than the general population.1-4 The overall goal of my proposed research is to identify biologic mechanisms mediating the increased risk of CRC during treated HIV infection and to identify targets for novel interventions to decrease this risk. Population-based and endoscopic studies suggest that the incidence of colorectal cancer (CRC) and its precursor, adenomatous polyps, is significantly elevated in HIV-infected individuals compared with the general population.5-8 Moreover, while the incidence of AIDS-related malignancies has declined significantly since the implementation of ART, the incidence of colorectal cancer has doubled.6 Systemic inflammation during HIV infection secondary to HIV- induced mucosal inflammation has been implicated as an important mechanism of HIV pathogenesis and non-AIDS complications. Microbial translocation, mucosal inflammation, and immune activation fail to normalize despite viral suppression.9-13 Indeed, colonic epithelial cell (CEC) turnover is dramatically increased in macaques after SIV-infection,9 and in humans, increased CEC turnover has been associated with the development of adenomas.14-16 Since activation of inflammatory pathways promotes CEC survival, HIV-induced inflammatory microenvironment in the gut mucosa may further augment the risk of adenoma formation (Figure 1).17-20 The objective of this application is to determine whether aberrant mucosal turnover and inflammation are associated with the development of colonic adenomas in HIV+ individuals, and to determine whether an intervention designed to decrease mucosal inflammation decreases CEC turnover in this setting. The specific aims of this proposal are: Figure 1. HIV 1) To determine the impact of untreated and treated HIV infection on CEC turnover and mucosal inflammation. Hypothesis: CEC turnover and lamina propria inflammation will both will be abnormally high in untreated HIV and will improve but not normalize during suppressive ART. 2) To determine whether CEC turnover and mucosal inflammation are associated with the presence of neoplasia in both HIV+ and HIV- individuals. Hypothesis: Epithelial turnover and ¿ Normal colonic epithelium ¿ Stromal cells + macrophages (red) ¿ Disruption of epithelial integrity ¿ Microbial translocation ¿ ¿ turnover and inflammatory cytokines ¿ Survival of transformed epithelial cells (blue) TNFa, IL-6 IL-1b, Cox2 inflammation will be associated with neoplasia in HIV+ subjects and will, in part, explain the excess prevalence of neoplasia in HIV+ versus HIV- individuals. 3) To determine whether mesalamine decreases mucosal inflammation and CEC turnover in treated HIV+ individuals in the context of an ongoing placebo-controlled trial. Hypothesis: Mesalamine will reduce both mucosal inflammation and CEC turnover in HIV+ individuals maintaining treatment-mediated viral suppression. The broad goal of this proposal is to characterize mucosal factors contributing to neoplasia risk in HIV+ individuals, to identify targets for interventions to reduce the risk, and to answer questions of biological and clinical significance. The study will leverage resources of an NIH- sponsored cohort of 1,380 HIV+ individuals with ongoing specimen banking (SCOPE), the infrastructure of another NIH-sponsored trial to examine factors affecting adherence to CRC screening, and a funded trial to examine how mesalamine may reduce T cell activation in HIV infection. A multidisciplinary approach will be employed, taking advantage of the candidate's prior training in epidemiology and new skills as part of the career plan (i.e. translational science) along with a team of mentors in HIV, epidemiology, and cancer biology and prevention. In this research environment, the candidate and team are uniquely positioned to meet the challenge of investigating how HIV may promote the development of adenomas through increases in epithelial turnover and mucosal inflammation. Page | 1